Molecular Mechanisms Regulating Pancreatic Delta Cell Function and Dysfunction

Project Summary
Islet glucose-stimulated somatostatin (Sst) secretion is lost in patients with type-2 diabetes (T2D) and in animal
models of the disease, which contributes to disrupted glucagon and insulin secretion. It is generally accepted
that Sst secretion from -cells occurs in response to elevated intracellular Ca2+, which primarily results from
endoplasmic reticulum (ER) Ca2+ (Ca2+ER) release. However, the mechanisms that control -cell Ca2+ER handling
and how they are altered in T2D are largely unknown. Data from our lab finds that the islet-enriched two-pore-
domain K+ channel, TALK-1, is an ER localized channel in that provides a countercurrent for -cell Ca2+ER release
and Ca2+ER leak. TALK-1-mediated augmentation of the electrochemical driving force for -cell Ca2+ER leak con-
strains Ca2+ER storage, which limits glucose-stimulated Ca2+ER release and Sst secretion. Further data show that
-cell Ca2+ER release and Sst secretion are amplified by glucose-induced allosteric activation of -cell Ca2+-sens-
ing receptors (CaSRs). Finally, our preliminary data provide the first evidence that diabetic conditions diminish
-cell Ca2+ER storage, which contributes to perturbations in glucose-stimulated Ca2+ handling and Sst secretion
under diabetic conditions. Based on these exciting preliminary data, the overall objective of this proposal is to
elucidate how -cell Ca2+ER is controlled and becomes disrupted during the pathogenesis of diabetes. This project
will test the central hypothesis that glucose-stimulated -cell Sst secretion is amplified by CaSR-mediated Ca2+ER
release, which is controlled by TALK-1 channel constraint of Ca2+ER storage. The rationale that underlies this
project is that understanding how CaSR and TALK-1 control -cell Ca2+ER handling and Sst secretion will expose
novel therapeutic targets for restoring glucose-stimulated Sst secretion and islet hormone secretion in T2D. This
project will be accomplished with the following two specific aims: 1) Determine how -cell CaSR controls Ca2+ER
handling, Sst secretion, and islet hormone secretion; and 2) Determine how TALK-1 channel control of Ca2+ER
release modulates -cell function and dysfunction. Under the first aim, transgenic mice with -cell ablation of
CaSR as well as human pseudoislets with ShRNA knockdown of -cell CaSR will be utilized to assess the roles
of the Ca2+-sensing receptor during secretagogue modulation of -cell Ca2+ handling and Sst secretion. Aim1 will
also determine how depletion of -cell Ca2+ER stores under diabetic conditions impacts CaSR signaling and Sst
secretion. Under the second aim, the function TALK-1 channels on -cell Ca2+ER handling and function will be
determined in mice with -cell specific ablation of TALK-1 and in human pseudoislets containing either -cells
with knockdown of TALK-1 or expressing dominant negative TALK-1 channel subunits. Furthermore, Aim2 will
determine how TALK-1 augmentation of -cell Ca2+ER depletion under the stressful conditions associated with
diabetes contributes to -cell dysfunction. This project is significant because it is expected to illuminate mecha-
nisms that alter -cell Ca2+ER handling and disrupt islet hormone secretion in T2D. Moreover, this project will
identify pharmacological strategies for normalizing Sst secretion and reducing islet dysfunction in T2D.

Public health relevance
Project Narrative The proposed project will determine the mechanisms that control pancreatic -cell endoplasmic reticulum (ER) Ca2+ (Ca2+ER) handling and their importance regulating islet hormone secretion. Results from this project are expected to provide significant insights into how glucose-stimulated-cell Ca2+ER handling becomes disrupted in T2D and perturbs islet hormone secretion. Thus, the proposed research project will generate fundamental knowledge about human islet -cells that will help reduce the burden of human illness in the context of diabetes.